BLINDED WITHDRAWAL OF DEPRENYL IN THE DATATOP EXTENSION

Longterm combined treatment of deprenyl with levodopa delays the appearance of milestones associated with the progression of Parkinson's disease (e.g. motor fluctuations, dementia).